Dopamine Modulation of Cortical Spine Synapses and Cognition in MPTP Monkeys

DESCRIPTION (provided by applicant): Parkinson's disease is usually characterized as a movement disorder; however cognitive abilities, such as working memory and executive function, decline at early stages of the disease in most patients. The changes in brain that underlie the cognitive deficits are not well understood. We hypothesize that reduced dopamine transmission in the prefrontal cortex in Parkinson's disease is a harbinger of detrimental morphological changes in pyramidal neurons in the prefrontal cortex whose function is necessary for normal cognition. Our data show that a partial loss of dopamine innervation to the prefrontal cortex in monkeys elicited by systemic low-dose MPTP treatment produces cognitive deficits in prefrontal cortex-dependent tasks. Other preliminary data show that there is a decrease of asymmetric (excitatory) synapses on the spines of dendrites on pyramidal neurons in the dorsolateral prefrontal cortex of MPTP-treated monkeys. Together these findings suggest that the number of spine synapses on dendrites in the prefrontal cortex is dopamine-dependent and may be a morphological substrate of the cognitive deficits induced by sustained reductions in dopamine neurotransmission in this region. Modulation of spine synapses number represents a novel neuroplasticity function for dopamine. That cognitive deficits are persistent in the motor-asymptomatic MPTP-treated monkey suggests that this is a good model for the stage of Parkinson's disease in which there are few if any noticeable motor abnormalities, but significant detectable cognitive deficits. The Specific Aims of this proposal will examine this new direction, by investigating the dopamine dependency and specificity of spine synapse changes in the motor-asymptomatic primate MPTP model, examining GDNF gene transfer and pharmacological strategies for their restoration, using biochemical, electron microscopic and behavioral methods, and taking advantage of the primate facilities at the St Kitts Biomedical Research Foundation. This research will use the best animal model available to examine causes and treatments for cognitive decline in Parkinson's disease, which has received scant research attention, despite its substantial impact on patients and caregivers, and ineffectiveness of available therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Parkinson's disease presently affects 1 to 1.5 million Americans, and this number is expected to increase with aging of the population: it is commonly viewed as movement disorder, but it also affects many facets of cognition even at early stages of the disease. The cognitive changes seen in Parkinson's disease are not well understood and have received relatively scant attention in research, despite the substantial impact they have on the patient and caregivers. The proposed research uses a primate animal model to pursue new leads on biochemical and morphological changes in the brain that may underlie the cognitive deficits, and tests novel gene therapy and pharmacological strategies for ameliorating the dysfunction. Project Narrative: Parkinson's disease presently affects 1 to 1.5 million Americans, and this number is expected to increase with aging of the population: it is commonly viewed as movement disorder, but it also affects many facets of cognition even at early stages of the disease. The cognitive changes seen in Parkinson's disease are not well understood and have received relatively scant attention in research, despite the substantial impact they have on the patient and caregivers. The proposed research uses a primate animal model to pursue new leads on biochemical and morphological changes in the brain that may underlie the cognitive deficits, and tests novel gene therapy and pharmacological strategies for ameliorating the dysfunction. __SpecificAimsTextDelimiter__ 2. Specific Aims Abundant data in rodents and primates have shown the dopaminergic innervation of prefrontal cortex is critical for normal executive function. Prefrontal cortex-dependent cognitive processes are deficient in the early stages of Parkinson's disease, despite this condition being traditionally characterized as a motor disorder. The cognitive dysfunction in Parkinson's disease is now receiving more attention, due to its substantial impact on patients and caregivers, and ineffectiveness of available therapy, and is the topic of NIH PA-09-033. Our published data show a decrease of dopamine (DA) function in the dorsolateral prefrontal cortex (DLPFC) of monkeys treated with the parkinsonian neurotoxin, MPTP. We have reported that MPTP-treated monkeys display cognitive deficits on prefrontal cortex-dependent tasks. In addition, our preliminary data show that there is a substantial loss of asymmetric (excitatory) synapses on dendritic spines of pyramidal neurons in the dorsolateral prefrontal cortex (DLPFC) of MPTP-treated monkeys. Together these novel data suggest that the number of asymmetric spine synapse on dendrites in the DLPFC is DA-dependent and the morphological substrate of the cognitive deficits induced by sustained reductions in DA neurotransmission in this region. Modulation of excitatory synapse number represents a novel function of DA in the brain. These behavioral, biochemical and morphological changes occur in the MPTP-treated monkeys that have overtly normal motor function ("motor asymptomatic"). The overall goals of these investigations are to use the motor-asymptomatic MPTP primate model i) to understand more fully the novel relationship between DA innervation and asymmetric spine synapse plasticity in the DLPFC, ii) to test whether the dopaminergic neurotrophic factor GDNF can restore the dopaminergic innervation to the DLPFC and cognitive performance in MPTP-treated monkeys, and iii) to test whether selective pharmacological restoration of DA neurotransmission in the DLPFC will normalize asymmetric spine synapse number and cognitive performance. Thus, this project has clinical relevance to the understanding and treatment of cognitive sequelae in Parkinson's disease. Specific Aim 1. Does the loss of dendritic spine synapses in the DLPFC correspond with sustained dopamine loss inflicted by MPTP? This aim will extend our data showing that MPTP treatment in the monkey causes a decrease in the number of asymmetric dendritic spine synapses in the DLPFC. Thus, we will determine whether the MPTP-induced loss of spine synapses varies as a function of the degree of DA loss in the DLPFC and other cortical regions. Overall, this aim will indicate the specificity of the loss of asymmetric spine synapses in the DLPFC, and whether DA loss can explain the observed changes. Specific Aim 2. Does AAV5-GDNF rescue prefrontal dopamine neurons, and reverse MPTP-induced changes in synapse number and cognition? When overexpressed in the striatum, the neurotrophic factor, GDNF, has been shown to protect and rescue nigrostriatal DA neurons from various insults. Our new Preliminary Data are the first to indicate that overexpression of GDNF in the DLPFC can restore DA innervation of that region after damage. As the mesoprefrontal DA system appears sensitive to the beneficial effects of GDNF, then overexpression of GDNF by a viral vector could provide a long term and localized protection of this innervation, which is necessary for critical cognitive functions. Thus, we will inject adeno-associated virus serotype 5 expressing GDNF (AAV5- GDNF) unilaterally in the DLPFC of MPTP-treated monkeys to test whether this treatment restores the DA innervation, and reverses the loss of asymmetric spine synapses. Dependent upon successful outcome of the unilateral study, AAV5-GDNF will be delivered bilaterally to the DLPFC to enable evaluation of this treatment on performance of a cognitive task dependent on the DLPFC. If this approach does not provide complete reversal of the MPTP-induced cognitive deficits, then in a separate study, AAV5-GDNF will be injected in both the DLPFC and dorsolateral caudate nucleus to test the effect of restoring DA levels at both these sites on cognitive performance. Specific Aim 3. Does selective elevation of prefrontal dopamine reverse the MPTP-induced loss of spine synapse number and deficits in cognition? As the loss of asymmetric spine synapses and cognitive deficits seems to be dependent on dopaminergic tone in the DLPFC, then restoration of DA may reverse these changes. While several drugs have the potential to elevate DA function in the prefrontal cortex, we have chosen to test this hypothesis using olanzapine, a drug that produces a regionally-selective increase in DA in this region, together with a demonstrated effectiveness in ameliorating cognitive deficits in primate models or in humans. The object retrieval detour (ORD) paradigm will be used to evaluate prefrontal cortex-dependent cognitive function in drug-treated MPTP monkeys and controls.